CONTRACT ORIENTATION & KICKOFF MEETING FOR R&D SERVICES UNDER "PRECLINICAL TOXICOLOGY OF SMALL MOLECULE DRUGS DEVELOPED FOR CANCER AND OTHER INDICATIO

This Task Order will be for Contract Orientation and Kickoff Meeting for Contract "Preclinical Toxicology of Small Molecule Drugs Developed for Cancer and Other Indications"